Mechanisms of Ca2+/calcineurin-mediated organ size restoration during zebrafish fin regeneration

PROJECT SUMMARY
This project provides the applicant with Ph.D. training in cell and developmental biology. Thesis research will
further our understanding of how regenerating organs restrain outgrowth to return to their uninjured form.
Zebrafish rapidly and robustly regenerate their fins to their original shape and size following injury. A fibroblast-
derived, 'niche' blastemal sub-population promotes the progressive formation of replacement tissue. However,
the niche proportionally depletes over regenerative outgrowth, exhausting as the original fin size is restored.
Disrupted niche depletion in longfin mutants with ectopic expression of a potassium channel leads to
disproportionately long fins. Small molecule inhibition of the Ca2+-dependent phosphatase calcineurin also
prolongs regenerative outgrowth leading to long fins. Other long-finned models, including a new loss-of-function
voltage-gated Ca2+ channel mutant, further tying ion signaling involving Ca2+/calcineurin to outgrowth control.
However, the gene regulatory mechanisms and downstream cell behaviors by which Ca2+/calcineurin signaling
promotes niche depletion and subsequently fin size are unresolved. This project aims to define how
Ca2+/calcineurin and niche depletion gradually terminate fin outgrowth to help explain a classic mystery of robust
organ size restoration during regeneration. Ca2+/calcineurin likely regulates a transcriptional pathway to drive
niche depletion, possibly by favoring re-differentiation over niche cell renewal. However, the applicant’s
preliminary data using long-term live imaging of a transgenic reporter line shows apoptotic niche cells within
regenerating fins. This suggests Ca2+/calcineurin instead could drive depletion by programmed cell death.
Together, these results support the applicant’s hypothesis that decelerating regenerative outgrowth is regulated
by a Ca2+/calcineurin-dependent gene regulatory pathway facilitating niche depletion by re-differentiation and/or
apoptosis. The applicant will explore this hypothesis with three aims. Aim 1 will Determine if ion signaling
regulates calcineurin activity in niche cells to restrain fin outgrowth. Aim 2 will Define transcriptional targets
downstream of voltage-gated Ca2+ channels and calcineurin signaling. Aim 3 will Determine if Ca2+/ calcineurin
depletes regenerating fin niche cells by re-differentiation and/or apoptosis. Completing these aims will connect
ion signaling (or “bioelectricity”) and organ size control to gene regulatory pathways and downstream cell
behaviors in a compelling adult regeneration model. These insights will advance our mechanistic understanding
of organ size control with potential biomedical significance for regenerative medicine and overgrowth-associated
diseases including cancer. The applicant also will pursue activities supporting their professional development
and acquisition of advanced imaging and bioinformatics, mentorship, and science communication skills to
prepare them for a research leadership career.

Public health relevance
PROJECT NARRATIVE Adult zebrafish robustly regenerate amputated fins to their original shape and size, providing a tractable model to understand organ size control. Uncovering mechanisms restraining fin outgrowth as size is restored will further our understanding of human diseases, including cancer, characterized by excessive tissue growth. Further, the project will inform novel regenerative medicine approaches to enhance organ repair.